Expansion of NCD Research Capacity in Thailand with Outreach to Indonesia

D43 Renewal ‘Expansion of NCD Research Capacity in Thailand with Outreach to
Indonesia’
The D43 Renewal will address the rapid rise in non-communicable diseases (NCD) occurring in
both Thailand and Indonesia. This epidemiologic transition reflects advances in socioeconomic
development and progress in battling the most virulent infectious diseases. However, the
consequent unprecedented pace of population aging is helping to fuel the growing burden of
NCDs in these countries. While high-income countries have had over 100 years to adjust to
demographic and epidemiological transitions, many LMICs – including Thailand and Indonesia –
have experienced that shift in less than one quarter the time. The volume, speed of growth, and
complexity of health care needs of older adults with NCDs will challenge the health care
systems of Thailand and Indonesia. These health systems have traditionally focused on
treating infectious disease, and the prolonged nature of NCDs will challenge infrastructure and
increase health care costs. Tackling this escalating problem requires two important strategies:
1) Implementing multi-sectoral policies aimed at reducing population risk that come from
research-based understanding of population risk and age-related disease expression; and 2)
effective and affordable health sector interventions that come from evidence-based intervention
studies. Both strategies require appropriate research produced by a committed, local scientific
community.
The proposed D43 training plan builds on a previous successful D43 in which the
Praboromarajchanok Institute for Health Workforce Development (PIHWD) in Thailand and the
University of Michigan School of Nursing (UMSN) collaborated to train a cadre of post-doctoral
fellows who received high quality training in analytical methods and research designs. The
program also included other capacity building activities. Specific aims and activities for this five
year renewal program are to: 1) Implement an early-mid career post-doctoral traineeship for 15
Thai/Indonesian trainees – preparing them to conduct scaled-up NCD research projects; 2)
Strengthen the institutional research capacity for NCD research in the scientific hubs
established in the prior D43 – activities include annual capacity building conferences,
development of research networks and direct consultation to departments and research units to
assist them in expanding research activities; 3) Expand capacity building activities to PIHWD
D43 training affiliate, the Padjadjaran University of Indonesia, by including Indonesian scholars
in the post-doctoral training program and all other activities of the D43; and 4) to provide
consultation for infrastructure building to advance eLearning activities – a strategy that supports
sustainability of training capacity in Thailand.

Public health relevance
D43 Renewal ‘Expansion of NCD Research Capacity in Thailand with Outreach to Indonesia’ Project Narrative The demographic shifts in both Thailand and Indonesia are associated with notable increases in the incidence and prevalence of non-communicable diseases (NCDs). To meet the challenges of the escalation in NCDs, The Praboromarajchanok Institute for Health Workforce Development (PIHWD) in Thailand and the University of Michigan School of Nursing (UMSN) will engage in a Training and Capacity Building Program for scientists and institutions in Thailand and Indonesia. The Program will provide needed and significant advancement of research that will be essential to policy and resource planning to manage the challenges posed by the rapid rise in NCDs in both countries.